Sensitive and Quantitative MS-bases Glycomic Mapping Platform

DESCRIPTION (provided by applicant): Because of the pressing needs to comprehensively understand the biological attributes of glycosylation in many important biological functions such as the immune response, cell development, cellular differentiation/adhesion and host-pathogen interactions, glycomics and glycoproteomics continue to be highly dynamic and interesting research areas. Moreover, aberrant glycosylation for decades has been recognized as the attribute of many mammalian diseases, including osteoarthritis, cystic fibrosis and cancer. The diverse biological roles of glycans and their implications in diseases have created a demand for reliable quantitative glycomic approaches, permitting sensitive monitoring of glycans in biological systems. The aim of this proposal is the creation of glycomic mapping platform enabling the automated identification, annotation and quantitation of glycans derived from biological samples. The platform comprises of both analytical methods and bioinformatic tools. The analytical methods are based on reversed-phase liquid chromatography and mass spectrometry of permethylated glycans while the bioinformatic tools facilitate automation of interpretation and quantitation. The glycomic mapping platform will be employed to understand the biological attributes of glycan in disease development, such as cancer and cardiovascular diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research activities are aimed at the creation of analytical methods and bioinformatic tools to facilitate rapid and detailed characterization of glycoproteins. Such effort is aimed at facilitating better understanding of the biological roles of glycosylation. The resulting methods and tools will create a glycomic mapping platform that will allow sensitive, reliable and reproducible monitoring of alteration in glycosylation as a result of perturbation in biological systems such as changes in glycosylation as a result of disease progression.